In vitro cultivation and genome sequencing/annotation of Enterocytozoon bieneusi

Abstract
Enterocytozoon bieneusi (Eb), an intracellular spore-forming microsporidian fungus, represents the most
clinically significant opportunistic infection associated with persistent diarrhea and wasting, occurring in up to
30%–50% of individuals with HIV/AIDS and in immunosuppressed cancer and organ transplant patients. Chronic
infections in humans and rhesus macaques share remarkable similarities, primarily localized in the upper small
intestine, gallbladder, and bile ducts. The Tufts group has previously pioneered methods for purifying Eb from
infected humans and macaques, facilitating genomic surveys, diagnostic antibody reagents’ development, and
successful propagation of Eb in immunodeficient rodents. The group has additionally a well-established
hollowfiber cultivation system. The U. of Maryland group has an impressive set up of various in vitro models of
human intestinal and gallbladder mucosa. The two teams have a long record of collaboration and are eager to
harness these resources to advance our research on this critical pathogen. Previous attempts by few
investigators to continuously cultivate Eb in cell culture monolayers have been unsuccessful. As mentioned
above, our team has the knowledge and hands-on skills to deploy several new in vitro cultivation techniques.
We have assembled a unique collection of human specimens, including (i) stem cells isolated from the terminal
ileum and gallbladder, (ii) their ex vivo explants counterparts, and (iii) a continuous supply of well characterized
source of Eb spores of macaques and human sources, all of which will play an integral role in our proposed
research.
R61 Phase which includes 3 Specific Aims will develop and optimize in vitro culture systems for long-term
continuous propagation of Eb, deploying a) human-derived organoid of polarized epithelial cells, b) organotypic
model of the human intestinal mucosa using a rotating-wall-vessel bioreactor and c) separately, evaluating the
hollowfiber bioreactor system.
R33 Phase which include 3 Specific Aims will confirm and validate the leading system developed under R66 and
will in addition complete the sequencing of the Eb genome to improve annotation supporting future genetic
research and analyze the transcriptome of in vitro infected cells.
In conclusion, cell culture systems of continuous Eb growth and genome sequencing will in future facilitate
developing techniques for genetic manipulation of Eb to understand Eb's biology, pathogenicity and host-
pathogen interactions, and development of safe and effective drugs to treat Eb infections.

Public health relevance
Narrative: Enterocytozoon bieneusi is a fungal infection which infects and causes serious disease in immune deficient people, which includes people with HIV/AIDS, immunosuppressed cancer and organ transplant patients, and children with chronic diarrhea and wasting in developing countries. The infection has been difficult to treat because of lack of laboratory tools such as propagation in cell culture for drug testing and better understanding of its genetic structure.